College Aged Substance Use in Educational Settings: Outcomes for Students with ADHD (CASE4ADHD)

Attention-deficit/hyperactivity disorder (ADHD) is a chronic neurodevelopmental disorder that affects 6% of US college
students. Young adults with ADHD are less likely to enroll in college and those who do earn significantly lower GPAs.
These students are susceptible to a range of adverse outcomes including increased risk-taking, higher rates of
criminality, and higher prevalence of comorbid disabilities. One of the most common comorbid conditions of adult
ADHD is substance use disorder (SUD) with nearly 30% of those with ADHD diagnosed with a non-alcohol
related SUD during their lifetime and 42.7% with an alcohol use disorder. However, substance use does not
explain the relationship between ADHD and poorer academic outcomes. Instead, ADHD and substance use confer
unique and substantial risks for academic functioning placing college students with ADHD who use substances at a
greater, compounded risk, for adverse outcomes. Extant research regarding substance use among college students
with ADHD has been primarily drawn from 4-year colleges using cross-sectional designs. Therefore, the current
literature base may represent only a snapshot of the highest functioning subgroup of college students with ADHD.
There is a critical need to better understand the substance use experiences of all college students with ADHD to
reduce harm and promote academic success. A total of 100 first-time first-year college students (50 from 2-year
institutions and 50 from 4-year institutions) will be recruited for this study. This project aims to: (a) demonstrate the
feasibility of recruiting and retaining first-year college students with ADHD over one-year using responsive ecological
momentary assessments, (b) objectively and qualitatively describe the substance use experiences of first-year of
college students with rigorously defined ADHD, and (c) identify malleable factors that may inform clinical decision
making and future intervention research to prevent or reduce substance use. Results will provide rich preliminary date
using both traditional assessment (e.g., interviews, rating scales) and responsive EMA to drive further investigation
and inform clinical practice as it relates to preventing or reducing substance use among college students with ADHD
at 2- and 4-year institutions. Results will provide the most detailed data regarding substance use among college
students with ADHD via response EMA methodology. Second, this study will be the first to detail substance use
among college students with ADHD across their first year at 2-year institutions relative to their peers at 4-year
institutions and will yield vital information for understanding the needs of these students in settings within which they
are most likely to enroll (i.e., 2-year institutions).

Public health relevance
This project is relevant to public health as nearly 43% of adults with attention-deficit/hyperactivity disorder (ADHD) meet criteria for a substance use disorder (SUD) with combined societal cost of approximately $317 billion dollars per year. This project seeks to understand the rates and patterns of substance use among 2- and 4-year college students with ADHD in order to facilitate the development of new interventions to promote success during college for these individuals. College success is associated with greater lifetime earnings, increased likelihood of participating in healthcare and retirement plans, higher tax revenue, lower use of public assistance, lower substance use, and lower rates of incarceration suggesting resultant interventions will lower the financial impact of ADHD and SUD on the US economy